CSHL Advanced Techniques in Molecular Neuroscience Course

ABSTRACT
CSHL Laboratory Course in Advanced Techniques in Molecular Neuroscience
The proposed Cold Spring Harbor Laboratory (CSHL) course Advanced Techniques in Molecular
Neuroscience (ATMN), to be held annually in July 2020– 2024, is part of the CSHL's postgraduate
training program in neurobiology. ATMN is a short, intensive sixteen day hands-on course which
prepares students to enter directly into research that makes use of advanced and/or specialized
molecular techniques in contemporary aspects of neurobiological research. Experimental modules in
the course will include quantitative assays of RNAs bound to protein by crosslinking
immunoprecipitation (CLIP), translating mRNA isolation from specified neural subtypes (TRAP), tissue
clearing methodologies combined with single RNA molecule detection by hybridization chain reaction
(HCR), preparation of pure astrocyte and neural progenitor cell cultures, design and use of engineered
viral vectors in neuroscience research, design and use of CRISPR/Cas genome editing tools, practical
exercises in gene delivery systems in vivo, genome-wide assessment of chromatin state and
transcription factor binding by ATACseq and Cut & Run, and use and design of BAC transgenic
vectors. Experimental techniques are taught in the context of the broader conceptual advances that
they may provide. The course invites lecturers who have made significant contributions in their fields to
give up-to-the-minute reports on current research. The trainees are chosen by the course faculty from
larger pools of applicants and range from graduate students to senior investigators and research
physicians. Because of the short duration of this course, senior, as well as junior individuals can attend
and receive a short, intense period of training in an environment remote from other demands on their
time and attention. The ATMN course also provides an unusual opportunity for established scientists to
apply these advanced techniques to their own research interests, or to retrain in an important specialty
within neuroscience with which they may not be familiar. Methods and concepts taught in the course
are disseminated to the wider research community through the publication of laboratory manuals and
online resources.

Public health relevance
PROJECT NARRATIVE CSHL Laboratory Course in Advanced Techniques in Molecular Neuroscience This application seeks funds to support an advanced neuroscience lab-based short course at Cold Spring Harbor Laboratory, New York. The course aims to provide advanced training in state-of- the-art molecular approaches in neuroscience. Trainees include advanced graduate students, postdoctoral researchers and young faculty from throughout the United States and abroad. The selection process for entry into these courses is highly competitive, and trainees leave the course armed with new techniques, know-how and potential collaborators to apply to their own areas of research. A significant proportion of trainees subsequently undertake basic or applied research in diseases of mental health and/or neurological disorders. Methods and concepts taught in the course are disseminated to the wider research community through the publication of laboratory manuals and online resources.